Mechanistic details of key integral membrane enzymes for antimicrobial discovery

Project Summery
Equipment supplement – same as the parent grant

Public health relevance
Narrative Equipment supplement – same as the parent grant